Identity influences on psychosocial traits, biologic age, and cardiovascular disease disparities

PROJECT SUMMARY/ABSTRACT
Cardiovascular disease (CVD) disparities are increasingly attributed to the distinct social conditions in which
various social groups age. Socioeconomic and psychosocial factors are known to cause chronic stress that
may increase risk of CVD, but the mechanisms are not fully clear. It is therefore important to identify factors
that mediate or moderate the effects of social stressors on CVD. Geroscientific theory reconceptualizes chronic
disease as a product of sustained dysfunctional aging, offering additional avenues for understanding how the
social environment is internalized to influence health. Work emerging from this literature has identified
epigenetic dimensions of aging such as DNA methylation which appear particularly responsive to psychosocial
stressors. Epigenetic “clocks”, or measures of DNA methylation-based predictors of chronological age, health,
and mortality may serve as useful markers that can provide important missing information on the relationships
between social stressors, aging, and CVD. Furthermore, psychological factors may also play an integral role in
these pathways. Self-concept is a determinant of a number of identity-based psychosocial characteristics
associated with both epigenetic changes and CVD. These include dispositional traits such as optimism and
negative affect, as well as beliefs about self-worth and subjective social status. Importantly, these factors are
also known to influence the way individuals perceive and cope with stress. Antecedent to the psychosocial
traits which influence stressor appraisal and stress-responsive behavior, self-concept may therefore serve as a
viable point of intervening on the subjective identity characteristics which catalyze premature and dysfunctional
aging in the context of social disadvantage and predispose individuals to CVD. Incorporating a geroscientific
perspective, the applicant’s Identity Vitality-Pathology (IVP) model theorizes that certain self-concepts render
individuals particularly vulnerable or resilient to the health effects of social stressors by promoting or preventing
premature aging. The proposed IVP scale (IVPS) aims to measure these novel identity characteristics
hypothesized to predict aging-related psychosocial factors and cardiovascular health. The specific objectives of
the proposed study are to: 1) examine whether psychosocial risk and resilience factors predict biological age
as measured by epigenetic clocks using data combined from the Jackson Heart Study and the Atherosclerosis
Risk In Communities cohorts; and 2) use preliminary qualitative data to develop and finalize items for use in
the IVPS. R00 phase aims include examining the psychometric properties of the IVPS and assessing whether
self-concept as measured by the IVPS predicts CVD-related psychosocial traits and biological aging.
Ultimately, this work has the potential to identify additional targets for addressing racial and gender disparities
in healthy aging and CVD, particularly ways of favorably influencing epigenetic changes associated with
healthy aging.

Public health relevance
PROJECT NARRATIVE Socioeconomic and psychosocial factors are known to increase risk of CVD, but the mechanisms are not fully clear. Premature aging resulting from chronic stress may be one pathway. This study will examine whether identity characteristics influence susceptibility or resilience to premature aging under stress.